fMRI Studies of Risk for Mood and Anxiety Disorders in Children

This work is conducted under protocol 03-M-0186, NCT00060775. In this project, our group is examining biological aspects of risk for mood and anxiety disorders in children. Such work has major public impact. By identifying biological risks in children, information on novel treatments and preventative interventions will emerge. Given the understanding of most chronic mental illnesses as developmental disorders, such information holds the hope of dramatically influencing the mental well-being of many individuals. This project encompasses work examining the degree to which neurocognitive profiles vary among children and adolescents stratified with respect to personal and family history of mood and anxiety disorders. For these studies, personal history is defined based on early-childhood temperament. In a second protocol, we are acquiring fMRI data from a subset of these subjects. We have expanded our efforts in these protocols to encompass studies in juveniles across the full span of infancy, childhood, and adolescence. Thus, one set of studies is based among young adults who have been prospectively followed for more than two decades. A second set of studies is based in school-aged children who are now approaching adolescence. In both sets of studies, as well as the larger series of studies in this project, considerable progress continues to be made. A third set of studies examines infants. This set of studies has grown particularly rapidly in the past year, to the point that data collection activities during infancy is highly active. Across the three sets of cohorts, this project seeks to achieve a lifespan developmental perspective throughout the entire period of maturation. Studies on temperamental risk continue to dominate activities during the past year, as they had in the few years immediately prior. Thus, in this past year, studies on temperament occupy approximately 90% of all resources devoted to research on risk. During the past three years, we spent most of our efforts on collecting data in a childhood cohort, where the subjects are now approximately 17 years old. Both last year and this year, our work in this cohort continues to consistently replicate findings in across cohorts. We demonstrate the persistent influence of temperament on risk into for psychopathology. In this past year, we have focused most of our efforts on identifying neurocognitive factors that isolate subsets of children with particular temperaments who face the greatest risk for psychopathology. This has generated a steady stream of brain-imaging papers in both of these cohorts. A particularly important paper utilized longitudinal data to document changes in brain function occurring in tandem with changes in symptoms of anxiety. Other questions relate to the identification of factors that differentiate among children who are at high risk yet remain resilient from those who are at risk but manifest problems. Still other questions focus on different psychiatric outcomes from particular temperaments. Thus, we are comparing risk factors for behavioral and emotional problems. Finally, work has been particularly active among infants, where we are working with our collaborators at the University of Maryland to launch a large-scale study of infants. Work in this project over the next few years is designed to address these questions. Problems with anxiety tend to run in families. Thus, anxiety often occurs among children born to parents with anxiety disorders as well as in children born to parents with major depressive disorder (MDD). In adults, MDD involves dysfunction in prefrontal brain regions that regulate attention to emotional stimuli. These abnormalities: i) have been found primarily in adults with specific familial forms of MDD, ii) persist after recovery from MDD, and iii) relate to anxiety. In adults, some data suggest that anxiety disorders are also associated with prefrontal dysfunction. However, findings in anxiety appear most strongly related to attention, whereas findings in MDD appear most strongly related to memory. This has stimulated attempts to dissociate factors in children associated with risk for anxiety as opposed to MDD. This protocol is attempting to dissociate these aspects of risk, through behavioral and fMRI studies of emotion regulation in high and low-risk adolescents. In general, research in this area continues to occupy a shrinking amount of resources in our group. Finally, our most in-depth studies focus on the temperament of behavioral inhibition. This work is made possible through our strong collaborative relationship with Dr. Nathan Fox at the University of Maryland. Our studies in this area continued to grow and expand this year, as they had done in the immediately prior years. Dr. Fox has followed cohorts of approximately 600 infants as they passed though childhood. These children have received repeated assessments of their temperament. Temperament classifications in the sample during infancy and early childhood have been shown to predict behavior later in life. We have also completed a series of investigations in this sample. Results from these studies support the conclusions generated in other research within our group. Namely, this work establishes the presence of strong, consistent associations between the presence of and risk factors for mental illness in children and the presence of perturbed brain function. In the past year, our group continued to have significant success in charting relationships between temperament and brain function. We continue to publish widely in this area, having published more than 10 papers in this area during the past year, and we have acquired data from many subjects during the past 12 months. During the next year, we plan to continue to report results from completed research. This includes reports on subjects who now are in their late-20's, examining the manner in which early temperament relates to later brain function and psychopathology, expressed in early adulthood. Finally, we have completed studies in the younger cohort, with assessments when the subjects were approximately 16 years old, and we are initiating assessments when the subjects will be 17 years old. This led to many papers in various stages of completion. This includes reports from studies both in late adolescents and in pre-adolescent children. Overall, the results from these studies show that the seeds of temperament continue to be expressed throughout development. Behaviorally, these seeds are expressed in measures of task performance and signs of psychopathology. From a brain-function perspective, these seeds are expressed in measures of electrophysiology and fMRI. Moreover, these measures of brain function mediate and moderate the relationships between temperament and psychopathology. As such, the studies provide important information on understanding risk for psychopathology.